Development and Proof-of-Concept Trial of a Meaning and Theory-Based Physical Activity Intervention

PROJECT SUMMARY
Physical activity (PA) has numerous benefits, including reduced risk for chronic disease and cognitive
impairment, improved mental health and well-being, and increased longevity. However, when measured
objectively, only 5% of adults meet recommended PA guidelines of 150 min/week. Many interventions have
been developed to increase PA among insufficiently active adults, yet the effects are modest, and many people
return to inactive lifestyles after the intervention is completed. Meaning in life, the sense that one’s life matters,
makes sense, and has purpose, has been shown to be a robust predictor of PA. To date, no PA interventions
have thoughtfully incorporated meaning in life. A meaning-based approach is consistent with Self-
Determination Theory (SDT), a theory of human motivation and behavior. The overall goal of this project is to
systematically incorporate meaning in life and SDT principles into a web-based and text message intervention
(Meaningful Activity Program [“MAP to Health”]) to increase PA among insufficiently active adults in midlife.
The project will use Science of Behavior Change principles and the Obesity-Related Behavioral Intervention
Trials (ORBIT) framework to conduct a Phase IIa proof-of-concept pilot study of MAP to Health. The study has
two aims: (1) to develop and examine the acceptability of the technological and theoretical frameworks
of MAP to Health and (2) to determine whether MAP to Health is related to changes in theoretically
identified mechanisms of behavior change (meaning salience, basic psychological needs satisfaction,
and internal motivation). In an exploratory aim, we will assess how the intervention and mechanisms of
change are related to changes in PA. Participants will be adults in midlife (ages 40-64) who are insufficiently
active, are interested in increasing PA, do not have contraindications to engaging in PA, and are patients in a
large healthcare system in the Midwest. In Phase 1, we will develop the MAP to Health online web-based
interview that will be used to explore what is particularly meaningful to participants, how PA is consistent with
those goals, and what activities patients plan to engage in. Participants (N=12) will complete the interview and
rate the ease of use, usefulness, intention to use, and theoretical fidelity of the intervention. In Phase 2, we will
conduct a proof-of-concept pilot trial using a double-pretest single group design. Participants (N=35) will
complete a 4-week pretest monitoring period and an 8-week pilot trial of the intervention, with assessments of
SDT mechanisms and meaning salience at pretest (-4 weeks), baseline (0 weeks), midpoint (4 weeks) and
posttest (8 weeks). In addition, participants will wear accelerometers to assess PA during the 12 weeks. If the
hypotheses are supported, we will pursue a Stage III efficacy trial comparing MAP to Health to a PA reminder
text message intervention. MAP to Health is designed to be compelling and engaging to achieve results, yet
resource-sparing to achieve scalability, and has the potential to improve the health and well-being of
thousands of insufficiently active middle-aged adults.

Public health relevance
PROJECT NARRATIVE Physical activity is important for health and well-being, yet many adults are insufficiently active. This pilot study will develop and examine a mobile health intervention that encourages adults to use meaning in life as a motivator for increasing physical activity.